Methods to Rapidly Explore Combinatorial Diversity and Their Application to CRISPR-Cas9 Systems

PROJECT SUMMARY/ABSTRACT:
For decades, biologists have taken parts from disparate proteins and fused them in various
combinations to create engineered variants with user defined properties. Despite the success of
many of the generated tools (e.g. chimeric antigen receptors and enhanced CRISPR variants)
the methods by which these proteins are discovered are slow and labor intensive, limiting our
exploration to only a tiny fraction of potential protein space. Here, we introduce BArcoded
Combinatorial Engineering and Screening (BaCES), a method that enables the simultaneous
assembly and parallel testing of tens of thousands of combinatorial protein variants. The objective
of this proposal is to use BaCES to create a new generation of enhanced Cas9-based
transcriptional regulators, which will be combined with a novel experimental paradigm to probe
gene function within in vivo contexts. The rationale underlying this proposal is that, if successful,
we will create several transformative technologies and gain insight into the mechanism by which
neurons tolerate neurodegenerative insults. Herein we demonstrate the feasibility of our BaCES
platform and provide evidence supporting our unique approach to in vivo screening. To further
our research goals, we will: 1) use BaCES to generate and quantify the behavior of 27,000 Cas9
activators and repressors; 2) thoroughly validate across targets and cell types a new generation
of highly-potent Cas9 transcriptional modulators; and 3) apply these tools to perform a set of in
vivo genetic screens to uncover regulators of neuronal survival within a mouse model of
Parkinson’s Disease. This proposal is innovative from a technical perspective in that it creates a
new method for rapidly searching through combinatorial protein space and implements a new
paradigm for performing in vivo CRISPR screens within a complex cellular environment. It is also
innovative in approach as it utilizes a high-throughput platform to gain insight into the genes and
pathways that regulate neuronal survival within an in vivo model of disease. This work is
significant in that it will create a novel method for performing combinatorial protein screens,
identify a set of enhanced Cas9 activators and repressors to enable global research endeavors,
and uncover the biological processes that neurons use to tolerate neurodegenerative disease-
associated stressors. Our track record of producing widely adopted CRISPR tools, combined with
our preliminary data demonstrating the feasibility of the proposed work and a group of long-
standing committed collaborators, makes our team uniquely suited to carry out the outlined
interdisciplinary research.

Public health relevance
Project Narrative: Here we propose to develop a method for rapidly permuting through combinatorial protein space at rates two orders of magnitude greater than what is currently available. Using our approach, we will generate a set of advanced CRISPR-Cas9 transcriptional regulators, and apply these tools to perform a series of in vivo screens within an animal model of neurodegeneration. The outlined work will be impactful in several ways as we will establish a new paradigm by which designer proteins are developed, create a series of highly-potent CRISPR tools with which users can probe gene function, and provide a general framework for performing precise genetic screens within complex tissues.